The impact of host RANKL signaling on Salmonella Typhimurium pathogenesis

PROJECT SUMMARY/ABSTRACT
The proficiency of immune cells to react to environmental stimuli and mount specific responses are, in
part, due to robust gene expression profiles that involve coordinated regulation. Monocytes are unique amongst
immune cells in that they can also differentiate into osteoclasts (OCs) following exposure to the cytokine
Receptor Activator of Nuclear factor KappaB-Ligand (RANKL). Once thought to be important only for the bone-
resorbing function of OCs, RANKL is now known to regulate diverse facets of mammalian physiology outside of
the skeleton, including processes such as secondary lymphoid organ development, intestinal homeostasis, and
immune cell crosstalk, all of which are critical for host defenses against bacterial pathogens. Therefore, as
monocyte lineage cells in many different tissues experience RANKL signaling and undergo profound
transcriptional and epigenetic remodeling, RANKL has the potential to shape the outcome of infectious diseases.
The broad goal of this proposal is to define how RANKL alters monocyte responses to bacterial pathogens.
One model bacterial pathogen that replicates within monocytes during systemic dissemination is
Salmonella enterica serovar Typhimurium (STm). In preliminary studies, we found that RANKL-treated
monocytes harbor significantly higher numbers of intracellular STm. Moreover, these cells have decreased pro-
inflammatory IL-1β production. Based on our preliminary findings and literature from the osteoimmunology field,
the central hypothesis of this proposal is that RANKL signaling silences key monocyte effector genes to render
cells more susceptible to intracellular infection. Therefore, we also predict that RANKL blockade will modify the
outcome of infection in vivo. To test the hypothesis, Aim 1 will define how RANKL diminishes monocyte
inflammatory responses to STm by elucidating the effects of RANKL signaling on monocyte IL-1β regulation and
cell polarization. Aim 2 will explore how RANKL signaling increases STm replication in monocytes by examining
STm virulence in the context of host intracellular cues including iron availability and phagolysosome formation.
Aim 2 will also test how the RANKL signaling axis impacts STm disease in vivo using an FDA-approved RANKL-
blocking antibody. Collectively, the Aims will define how RANKL-mediated cellular reprogramming alters the
antibacterial and inflammatory properties of monocytes and modifies immune responses to STm.
The proposed project will be completed in the Cassat laboratory at Vanderbilt University, a world-leading
institution in biomedical research with a robust Medical Scientist Training Program (MSTP). The fellowship
synergizes with the applicant’s goal to conduct independent research at the interface of innate immunity and cell
biology. The training plan was designed to provide the applicant with foundational knowledge in host-pathogen
interactions and immunology while integrating clinical programming throughout, equipping them with translatable
expertise to conduct rigorous research focused on infection and immunity.

Public health relevance
PROJECT NARRATIVE Monocytes are unique amongst immune cells in that they can differentiate into bone-resorbing osteoclasts following exposure to the canonical osteoclastogenic cytokine Receptor Activator of Nuclear factor KappaB- Ligand (RANKL). However, it has recently become appreciated that RANKL regulates diverse facets of mammalian physiology outside of the skeleton, including processes like lymphoid organ development and immune cell crosstalk that are critical for host defenses against bacterial pathogens. The objective of this proposal is to define how RANKL-mediated cellular reprogramming alters the antibacterial and inflammatory properties of monocytes to shape the outcome of infectious disease.